How to build a rib cage for a cell: the patterning, growth, and maturation of the cortical microtubules in Toxoplasma

Project Summary:
The apicomplexans are unicellular parasites that infect a wide variety of vertebrates and invertebrates, and are
the causative agents for many diseases (e.g., malaria, toxoplasmosis, and cryptosporidiosis) that impact the
global population. Although differing greatly in host range and specificity, these parasites share similar major
features in their cellular architectures, with species-specific modifications. For example, they all have an array
of cortical (subpellicular) microtubules rooted in a ring-like structure (the apical polar ring), but the number of
cortical microtubules varies widely (e.g., two to four in P. falciparum asexual blood-stage parasites vs. 22 in T.
gondii). Chemical inhibition of microtubule polymerization results in ill-formed daughter cortex and inviable
progeny, indicating that the construction of the cortical microtubules is required for guiding the growth of the
parasite cortex and proper packaging the daughter organelles. Although their importance to parasite replication
has long been appreciated, the basic mechanism of patterning and development of the cortical microtubules
remains unexplored. In the last few years, we discovered that the structure and activities for both the apical
polar ring and the cortical microtubules are distinct in the mature vs. growing daughter parasites and can be
separated genetically. We will take advantage of this unique launch pad and combine it with molecular genetic,
microscopy, and comparative proteomics to explore the initiation of patterning (Aim 1), growth and maturation
(Aim 2) of the microtubule array. This project will open new avenues for discovering new druggable, parasite-
specific targets for treating toxoplasmosis, generate novel molecular and structural insights into the mechanism
through which complex cytoskeletal frameworks are assembled, and enable comparative studies of the
biogenesis of mcrotubule arrays in other apicomplexan parasites. When integrated with the naturally occurring
variations among these relatives, this will help to reveal the molecular basis for divergence of apicomplexan
cytoskeletal structures, an important part of the evolution of this group of parasites.

Public health relevance
Project Narrative: Toxoplasma permanently infects nearly 20% of the world's human population. When the immune system is compromised or underdeveloped, Toxoplasma infection causes major lesions in various tissues, and results in devastating consequences such as encephalitis and blindness, as well as developmental abnormalities such as hydrocephalus. Our study on the initiation, growth, and maturation of the parasite cytoskeleton will identify novel proteins critical for proliferation, and thus provide potential parasite-specific targets for developing new therapies to treating toxoplasmosis.